Uncertainty, inference, and introspection in the primate visual system

Title
Uncertainty, inference, and introspection in the primate visual system
Abstract
Perceptual systems offer a window onto a world that cannot be known perfectly. Uncertainty about the world
can arise externally, when sensory cues are incomplete or contradictory, or internally, when noise corrupts neural
representations. Ideal perceptual systems do not ignore uncertainty, but take it into account. For example, if a
sensory cue is ambiguous, prior experience should guide the interpretation of the environment. Likewise, the
reliability of sensory signals should inform confidence in perceptual decisions. When humans and monkeys
perform perceptual tasks, they often follow these normative predictions. This implies that the neural circuits which
process sensory information also survey the uncertainty of this information, and put this estimate to use for
perceptual inference and perceptual introspection. How they do so is not well understood. A more precise
understanding of the neural processing of sensory uncertainty and its role in perception and cognition may help
to advance the treatment of pathologies such as agnosia, autism, and schizophrenia. Recently, several
theoretical frameworks have been proposed that offer explicit accounts of the neural processing of uncertainty
in low-level sensory and high-level decision-making circuits (linear probabilistic population codes, quadratic
probabilistic population codes, temporal sampling models, and the curved manifold hypothesis). These
developments form the background for this proposal. We will trace the processing of sensory uncertainty from
its initial computation and representation in early visual cortex to its eventual use in informing confidence in
perceptual decisions and in regulating the integration of sensory signals and prior information in high-level
decision-making areas in prefrontal cortex. We will use the data we collect to compare and contrast the
predictions of various theories of neural coding. First, we will study V1 population activity in awake, fixating
macaques while presenting stimuli whose orientation uncertainty is manipulated in distinct ways. Next, we will
examine how neural activity in primary visual cortex informs confidence in a perceptual estimate of stimulus
orientation. Finally, we will identify how sensory uncertainty shapes neural population representations in
prefrontal cortex during a perceptual inference task. The outcomes of this work will not only enhance our
understanding of the visual system, but will also provide a novel experimental paradigm to study perceptual
introspection in animals and a novel computational tool for analyzing behavioral confidence reports.

Public health relevance
Public Health Statement Vision science seeks to understand how the visual system functions and aims to develop treatments for visual pathologies. The proposed studies to investigate the processing of visual uncertainty in cortex and its role in perception will provide rigorous steps towards those goals. The obtained knowledge may help to advance the treatment of cortical-based visual pathologies such as agnosia, dyslexia, and amblyopia.